Understanding and Targeting the Pathophysiology of Youth-onset Type2 Diabetes

The DISCOVERY study aims to extensively phenotype a large, diverse cohort of youth at risk for type 2 diabetes (T2D) as they transition through puberty, a critical window for the development of metabolic dysfunction. Through comprehensive biochemical, clinical, and psychosocial assessments, the study will track longitudinal changes in glycemia, insulin sensitivity, β-cell function, and behavioral and social determinants of health. By characterizing the pathophysiological trajectory of youth-onset T2D, DISCOVERY will help identify early indicators of disease progression and stratify youth according to risk. A robust biobank linked to rich phenotypic data will support in-depth analyses to inform the design of future precision prevention and intervention strategies. Input from local and central stakeholders will help guide study implementation and dissemination of findings.

Public health relevance
Type 2 diabetes in youth is an urgent and growing public health concern. DISCOVERY will provide critical insights into how biological, psychosocial, and social factors drive disease progression during puberty and will guide future efforts to prevent T2D in high-risk populations.